14-3-3 gamma regulation of peripheral kappa opioid receptor function

ABSTRACT
Nearly one third of the population of the United States suffers from chronic pain. This pain causes
major activity restrictions in nearly 11 million people. Opioids are used for the treatment of pain, but have many
negative effects such as respiratory depression, addiction, and sedation. As these negative effects are
mediated by the central nervous system, a promising approach for the safe and effective treatment of pain is to
target the peripheral nervous system. Signals are sent by the peripheral nervous system to the brain and are
interpreted as pain. By specifically inhibiting the transmission of these signals, pain can be alleviated. The
value of this approach is illustrated by the pronounced analgesic effectiveness of local anesthetics.
Peripherally restricted opioids can target peripheral neurons and overcome the limitations of local anesthetics,
such as motor neuron inhibition. However, opioid receptors in the periphery are uniquely regulated, and poorly
understood mechanisms of long-term inhibition reduce the effectiveness of peripherally restricted opioids. This
study has preliminary evidence that the regulatory molecule 14-3-3γ mediates long-term inhibition of
antinociception through the kappa opioid receptor (KOR). Further, 14-3-3γ appears to bias KOR signaling
towards the pronociceptive mitogen-activated protein kinase (MAPK) pathways. This fellowship will: (1)
establish that 14-3-3γ directly interacts with KOR, (2) identify KOR signaling pathways mediated by 14-3-3γ,
and (3) evaluate the changes in KOR nociceptive signaling in vivo. These proposed studies will elucidate the
role of 14-3-3γ in regulating KOR-mediated antinociception in peripheral sensory neurons. As a result, these
studies will have significant impact on the use of peripherally restricted opioids for the safe and effective
treatment of pain.
Additionally, these studies will serve as an outstanding training vehicle for the applicant. The innovative
research approach combines a heterologous expression system, rat primary neuronal culture, and behavioral
nociception assays, which will ensure comprehensive training in the fields of pharmacology, cellular signaling,
and rodent behavior. With the guidance of the applicant’s postdoctoral advisory committee, the training goals
of developing new techniques, expanding understanding in a new field, refining communications, and
producing research products will be realized. Ultimately, this fellowship will lay the foundation for a successful
career as an independent investigator studying opioid receptor signaling in human disease.

Public health relevance
PROJECT NARRATIVE The continued rise in opioid overdose deaths, despite the declared opioid epidemic, demonstrates the need for improved analgesics with reduced side effects. Peripherally restricted opioids would avoid dangerous effects mediated by the central nervous system, but poorly understood mechanisms inhibit opioid analgesia in the periphery. This project will elucidate the mechanism of a novel protein that inhibits opioid analgesia to facilitate the use of peripherally restricted opioid agonists for the safe and effective treatment of pain.